Administrative and Statistics Core

ADMINISTRATIVE AND STATISTICS CORE A ABSTRACT
The Administrative and Statistics Core (Admin and Stats Core) provides leadership, oversight and
administrative support for the research programs, as well as biostatistical support and oversight. In particular, it
provides administrative and fiscal management, clerical support, manuscript submission, meeting organization,
data management, quality control, and planning and evaluation of the grant, leaving the research investigators
free to concentrate on science. It has two specific aims, one focused on scientific and operational oversight,
which includes an Internal Advisory Board (IAB) and help from ad hoc External Expert Consultants (EEC). The
second aim provides administrative and fiscal oversight to the overall grant. Within this aim is included the
communication and consultation with the NCI program officer and other staff, progress reports and tracking
shared resource use. The key importance to the Core's services is the Core's biostatistical support, which
includes: 1) biostatistical design of laboratory and clinical studies, including prospective design of the sample
size calculations for murine studies proposed in all three Projects and design of sample clinical trial and
sample analyses in the clinical studies proposed in Projects 1 and 3; 2) statistical monitoring of studies to
ensure interpretability of results; 3) supervision and analytical assistance to multiple investigators regarding
study protocol data entry/statistical analyses and analysis software; 4) development of biostatistical
methodology for statistical problems in these projects; and 5) assistance with manuscript preparation.